Development and Pilot Testing of an Electronic Health Record-based Serious Illness Communication Intervention for Older Adults in the Emergency Department

PROJECT ABSTRACT
This is a National Institute on Aging (NIA) K23 proposal from Adrian Haimovich, MD/PhD, an emergency
medicine physician-scientist at Beth Israel Deaconess Medical Center and Harvard Medical School. Dr.
Haimovich is committed to becoming a national leader at the intersection of geriatric acute care, data science,
and electronic health record (EHR) interventions. While 75% of adults aged ≥65 years will visit an emergency
department (ED) within six months of dying, few ED clinicians incorporate patient end-of-life values into
medical treatment plans leading to goal-discordant care. In alignment with the new CMS Age Friendly Hospital
Measure, the goal of this proposal is to develop an EHR-embedded, transdisciplinary serious illness
communication intervention for the emergency department (SIC-ED) to help emergency clinicians solicit the
goals, values, and preferences of older adults at the end-of-life and incorporate them into decision-making.
With funding from an NIA T32 at Hebrew SeniorLife and a Harvard KL2, Dr. Haimovich developed the Geriatric
End-of-life Screening Tool (GEST), an automatable logistic regression algorithm that uses EHR data to identify
older adults in the ED with limited life expectancy for the SIC-ED intervention. Dr. Haimovich also performed a
survey of 100 ED patients aged ≥65 years, finding that only 37% of older adults in the ED had spoken to their
doctor about the type of care they would want to receive if they were very sick or at the end of life. To address
this gap, SIC-ED will incorporate four evidence-based facilitators of serious illness communication: (1)
proactive patient identification with GEST, a multilevel intervention comprised of (2) a patient activation
questionnaire and (3) engages transdisciplinary ED teams (e.g., physicians, nurses, and social workers), and
(4) be designed for EHR integration. Following the SALIENT EHR implementation framework, Dr. Haimovich
will (1) prospectively validate GEST over 3 months, (2) develop SIC-ED using a stakeholder-informed human-
centered design process, and (3) assess feasibility, acceptability, and preliminary efficacy in a two-site single-
arm pilot. The proposed 5-year plan accelerates Dr. Haimovich's career development as an independent
physician-scientist through training in (1) implementation of EHR predictive models, (2) human centered design
of EHR interventions, (3) conduct of clinical trials, and (4) leadership in geriatric emergency care. Dr.
Haimovich's mentorship team incorporates research expertise in implementing shared decision-making with
older adults, ED clinical trials, and ED palliative care. The culmination of this career development award will
ensure Dr. Haimovich has the advanced research skills and knowledge required to conduct a large, multi-site
trial of SIC-ED. The goal of this research is to establish SIC-ED as the national standard of care to help
ED clinicians incorporate the goals, values, and preferences of seriously ill older adults in their care.

Public health relevance
PROJECT NARRATIVE While over 75% of older adults will visit an emergency department within 6 months of dying, few emergency physicians incorporate patient values and preferences into their medical decision-making. The proposed electronic health record-embedded serious illness communication intervention for the emergency department (SIC-ED) will incorporate proactive patient identification using a prognostic mortality model I developed during my NIA T32 and Harvard KL2 training as well as a stakeholder-informed, evidence-based communication guide to support transdisciplinary ED team members including physicians, nurses, and social workers in having conversations with seriously ill older ED patients to elicit their goals for future care. In alignment with the new CMS Age Friendly Hospital Measure, this study will allow me to develop SIC-ED and to determine feasibility and acceptability on both increasing documentation of these conversations in the electronic medical record as well as patient reported feelings of being heard and understood by the ED team in a two-site single-arm pilot.